Dissolved Phase Hyperpolarized Xenon-129 MRI: a novel biomarker to quantify pulmonary pathology in young healthy e-cigarette users

Project Summary
Over the past ten years, electronic cigarettes (e-cigarettes) have been commercialized as a “less harmful”
alternative to traditional cigarettes. Preclinical models show that e-cigarettes cause pulmonary epithelial,
endothelial, and vascular dysfunction similar to human COPD. E-cigarette use has also been associated with
cardiac and pulmonary diseases, including severe respiratory failure. However, we still do not clearly understand
how e-cigarette uses impacts lung health in the early days of use. Therefore, there is an urgent need to establish
the health impact of e-cigarettes on human lungs. Conventional diagnostic tools such as pulmonary function
tests (PFT) and multi-detector computed tomography (MDCT) are limited in detecting subtle but potentially
significant early pathologies from e-cigarette use. To address this shortcoming, we propose to use 3D
hyperpolarized xenon-129 MRI (HXeMRI) as a new imaging biomarker. Our group has optimized the HXeMRI
technique to quantify the regional physiology of pulmonary microcompartments (airway, interstitial tissues, and
capillary vasculature) with high resolution and sensitivity. Our HXeMRI pilot study demonstrated that healthy
young e-cigarette users with normal PFT had dysregulated gas exchange in the interstitial tissue and pulmonary
capillary compartments compared to age-matched controls. Based on these preliminary data, we hypothesize
that quantitative HXeMRI signatures can detect clinically relevant early physiologic changes in the lungs of
healthy young e-cigarette users. We speculate that a cardiopulmonary exercise test (CPET) will exacerbate
these dysregulated lung functions and limit healthy young e-cigarette users’ exercise capacity by reducing their
oxygen uptake. Therefore, we hypothesize that the CPET, a clinical diagnostic standard, will corroborate
HXeMRI signatures. To the best of our knowledge, this is the first time any non-invasive technique has revealed
dysfunctional gas exchange capacity in healthy young e-cigarette users with normal PFT. Our two aims are: (1).
Aim 1: Determine the impact of e-cigarette use on pulmonary gas exchange capacity in interstitial tissues and
capillaries using HXeMRI, and corroborate the HXeMRI signatures with the CPET for 40 young adults with e-
cigarette use at an initial visit (V1) and a follow-up visit 12-months later (V2), compared to 40 age-matched
healthy control subjects without e-cigarette use as controls; and (2). Aim 2: Determine the acute effects of e-
cigarettes on pulmonary gas exchange capacity in interstitial tissues and capillaries among the e-cigarette users
from Aim 1 by HXeMRI at baseline and after being perturbed by a dose of e-cigarettes during the V1 and V2
evaluations. The result of our proposal is anticipated to yield a comprehensive understanding of the health impact
of e-cigarette use and bring forth gas exchange signatures of HXeMRI as a new diagnostic tool to assess these
patients.

Public health relevance
NARRATIVE For healthy young adults who use electronic cigarettes (e-cigarettes), we still do not clearly understand their health effects. This significant knowledge gap hampers effective medical management and policy decision. In this proposal, we will deploy a sensitive imaging signature, hyperpolarized xenon-129 MRI, to determine the pathologic lung effects induced by e-cigarette use.